Advanced Lab Technologies Core

PROJECT SUMMARY/ABSTRACT
Advanced Lab Technologies Core (Core I)
One of the greatest added values of the Harvard University (HU) CFAR has been accelerated member access
to new and emerging technologies. Science is accelerated by changes in technology, and the evolution of flow
cytometric, imaging and genomic techniques continues at a rapid pace. However, access to such technologies
and associated computational methodologies is an ever increasing and challenging barrier to individual
investigators. Acquisition and optimization of instrumentation and softwares and making them accessible
remains the primary focus of the HU CFAR Advanced Lab Technologies Core (ALTC). Making these cutting-
edge technologies available to HU CFAR users adds critically needed value to their studies of HIV reservoir
and cure, virus-host interactions, therapeutic interventions, and vaccine development. The consolidated ALTC
offers a unified pipeline of immunology services, molecular biology services, and training opportunities
strategically placed to serve the greater Harvard community at the most effective fiscal value. Indeed, the
ALTC serves hundreds of HU CFAR users and their global collaborators supported by more than 100 NIH-
funded grants/contracts across ten different NIH Institutes and Centers. The ALTC also continues to focus on
providing critical individualized technical support to Early Career Investigators (ECI), including dozens of HU
CFAR Developmental and Mentoring Core awardees. At the current time, much of the identified need for
members is in the capture of information regarding the phenotypic and functional state of individual cells,
indexing these samples, and then capitalizing on this precious biomaterial to develop a comprehensive picture
of the genomic landscape that exists in particular disease states. To ensure that all Harvard University CFAR
laboratories have access to this remarkable analytical power, this core will facilitate access to such
technologies through the following aims:
1) Provide HU CFAR member access to state-of-the art instrumentation and techniques.
2) Provide user training in all ALTC technologies, as well as computational assistance.
3) Build a virtual community using state of the art sharing and distribution tools.